Data Science Core

Data Science Core Abstract
The WV-INBRE Data Science Core (DSC) is a centralized resource that will provide training and
education in data science for biomedical researchers and students, access to technical expertise
in data science, and access to cyberinfrastructure for network researchers. The DSC will
collaborate closely with the WV-INBRE Sequencing, Molecular and Related Technologies
(SMART) Core to provide seamless, integrated services in genomics to investigators at the lead
and undergraduate institutions in the WV-INBRE network. Genomic services offered by the DSC
and SMART Core will include experimental design, library preparation and next-generation
sequencing (NGS), and data analysis and interpretation. The two cores will continue to provide
whole genome, whole exome, RNA-Seq, microbiome and global chromatin sequencing, and will
add as new NGS services single-cell and spatial transcriptomics. The DSC will build expertise in
data science in the WV-INBRE network by developing a comprehensive series of online training
modules. The training modules will be freely available for self-study and will be used as source
material for annual instructor-led training workshops in data science and its applications to
biomedical sciences. The training modules will also be used in undergraduate education, forming
part of an expanded Summer Bioinformatics Bootcamp for undergraduates in IDeA states in the
southeast region, as well as in undergraduate courses which will be developed at West Liberty
University as part of a bioinformatics program. The DSC will provide access to cyberinfrastructure
both by maintaining a high-performance computing (HPC) cluster at Marshall University, and by
providing access to cloud computing resources to network investigators via a membership of the
Ohio Supercomputer Center. Our primary aim is to provide services and build expertise in
data science and its applications to biomedical sciences. This expertise will empower
investigators to bring machine learning, big data, artificial intelligence, and related technologies
to their biomedical research, enhancing their ability to gain a deeper understanding of chronic
diseases that are prevalent in West Virginia.

Public health relevance
Data Science Core Project Narrative The Data Science Core (DSC) is a centralized resource that provides training, services, and expertise in data science, machine learning, artificial intelligence, and related technologies. These services and expertise will allow investigators to use these technologies to enhance their understanding of the mechanisms of disease and lead to the discovery of novel treatments.